Preclinical Evaluation of Radioprotectin-1 for Mitigation of GI-ARS

Project Abstract
Project Abstract has not changed from original submission

Public health relevance
Project Narrative Project Narrative has not changed from original submission